Advancing Resources for Systematic Reviews and Meta-Analyses of Complementary and Integrative Health Interventions

PROJECT SUMMARY
This collaborative project, Mindfulness and Integrative Health Data Network (MINDNET), responds to RFA-AT-
25-005 by creating a highly usable and accessible data repository of complementary and integrative health (CIH)
interventions, producing high-quality reviews and methodology papers, and creating pilot awards and providing
education, training, and communications to enhance impact. There has been exponential growth of clinical trials
of CIH interventions and a strong need to stay abreast of new findings by efficiently synthesizing information
across PICOs (Population, Intervention, Comparison, and Outcome), evaluating new models and formats of CIH
programs (e.g., via mobile delivery), and fostering timely reviews and meta-analyses for key stakeholders
including health insurers, policy makers, patients and providers. Greater support and resources are also needed
for the scientific community to utilize CIH data with rigorous methodology, state of art practices, and to
disseminate review findings for key stakeholders. The MINDNET project will build on our team’s expertise in
systematic reviews and meta-analyses of mindfulness-based interventions (MBIs) and other CIH interventions,
experience creating and maintaining a public repository for meta-analyses, and implementation science work
with key stakeholders to identify the highest priority evidence needs and disseminating findings for evidence-
informed policy and practice. Specifically, Aim 1 will involve creating a data repository of CIH interventions
through systematic literature search and coding. Strategic planning meetings with advisory committee and
NCCIH priority will inform the CIH intervention domains (e.g., mindfulness, yoga, tai chi, qigong, acupuncture,
chiropractic) and outcome areas (e.g., pain, psychiatric symptoms). An open-access data repository will be
produced as a result, with regular updates every 6 months. The platform will be built on prior success of Metapsy,
a public data repository for reviews and meta-analyses of psychotherapy, and will incorporate advanced features
for data interface. Aim 2 will capitalize on our team’s expertise to produce high-quality meta-analyses of MBIs,
as well as methodology papers aiming to advance the science of CIH reviews and clinical trial methodology. Aim
3 will generate non-MBI focused pilot awards to produce systematic reviews and meta-analyses in key areas of
CIH, with resources, coding support, and quality assurance provided by the core MINDNET team. Aim 3 will also
include education and training via asynchronous and synchronous forms to foster rigorously conducted reviews,
and communications to increase the impact of MINDNET and its research. The long-term vision of MINDNET is
to (a) foster open science, transparency, and rigor in CIH reviews and clinical trials; (b) advance CIH science by
providing clear synthesis of evidence, addressing key gaps in the current literature and identifying priorities for
future research; and (c) foster collaboration and training of CIH scientists. In conclusion, this R24 grant
application will provide a living, sophisticated, and advanced data repository of CIH interventions and foster
efficient, high quality evidence syntheses used by key stakeholders for societal impact.

Public health relevance
PROJECT NARRATIVE Clinical trials of complementary and integrative health (CIH) interventions, along with their applications, have grown exponentially and there is an urgent need for rigorously conducted systematic reviews and meta-analyses to synthesize evidence to guide stakeholders and inform policy and decision making. We propose the Mindfulness and Integrative Health Data Network (MINDNET) to create a highly usable and accessible data repository, with advanced web interface and R programming for data analysis, as well as pilot awards and asynchronous and synchronous education and training. MINDNET will generate high quality systematic reviews, meta-analyses, and methodology papers from the investigative team and pilot awards to provide clear synthesis of evidence across populations, interventions, conditions, and outcomes (PICOs) for stakeholder use, as well as training and education to foster skills, collaboration, and innovation within the CIH scientific community.